LF-TIMING: Large-scale label-free profiling of cell-cell interactions

7. Project Summary/Abstract
There is a compelling need for technologies that can quantitatively profile cell-cell interactions on a large scale,
especially the interactions of immune cells with tumor cells and quantify detailed measurements of crucial events
including cell-cell contact patterns, contact frequencies, contact durations, cell death, interaction-related
movement patterns especially pursuit, avoidance, arrest, movement failures, and target cell killing behaviors,
cell division, and others. The TIMING™ (Time-lapse Imaging Microscopy In Nanowell Grids) assay is a powerful
and versatile high-throughput in vitro assay that meets this need. In its current form, TIMING assay analysis
software relies on multi-channel fluorescent imaging to identify cell type and location. This imposes an inherent
limitation, as even the best available high-throughput time-lapse imaging instrumentation has 4 – 5 fluorescent
channels of which 2 – 3 channels must be devoted to labeling effector and target cells, leaving only 1 – 2 channels
for the customer to incorporate antibodies or probes of investigational interest. There is a compelling need to
free up fluorescence channels so the customer can incorporate 3 – 4 investigational probes concurrently. This
will greatly enhance the value of the TIMING assay for the customer by allowing them to study the localization
and dynamics of multiple investigational probes concurrently in their spatiotemporal context.
Achieving this goal requires computer vision methods capable of accurately and reliably analyzing label-free
phase-contrast video recordings to detect, segment, and classify cells, track their movements, detect key events
like cell death and mitosis, and profile cell-cell interactions while coping with focus loss. This will not only free up
multiple fluorescent channels but also reduce the phototoxicity, enabling cell co-cultures to be imaged over
longer durations and at higher frame rates. Finally, there is a need for the video array analysis to be completed
while the cells are still live (~ 2 hours maximum), to identify crucial cells of interest (e.g., exceptionally motile
serial killers) for robotic retrieval and downstream processing, including clonal expansion and transcriptomic
profiling. The goal of this project is to develop LF-TIMING (Label Free TIMING), an integrated computer vision
system that meets the above-mentioned needs, leveraging advances in deep neural network-based cell
segmentation, tracking, classification, and focus restoration methods.

Public health relevance
8. Project Narrative Advances in computer vision have provided new capabilities for rapid, functional analysis of single cells. We have used these AI-enabled techniques to profile cells used for immunotherapy to understand which therapies perform best and why. In this project, we will create a commercially scalable prototype integrated software system capable of the same analysis on cells that are not fluorescently labelled (label-free). This software will be based on new AI models trained on millions of images of cells and optimized for fast, high-throughput single cell analysis by any customer without computational science backgrounds.